Identifying causal mechanisms of metabolites in family-based association studies of childhood asthma

Abstract
Asthma is a chronic disease with a substantial public health burden. Asthma has both genetic and environmental
risk factors; however, metabolomics has the distinct advantage of reflecting the net result of genomic and
environmental influences by profiling the small molecules (i.e., metabolites) that reflect the complex physiological
processes manifesting as difference in clinical features observed in asthma. The global metabolome is therefore
well-suited to capture both unique and common disease mechanisms that drive a range of lung function. It is
critical to understand the genetics underlying the metabolome and lung function for accurate classification and
improved treatment responsiveness across the spectrum of asthma.
The Genetic Epidemiology of Asthma in Costa Rica (GACRS) cohort recruited children with mild-to-moderate
asthma from the Central Valley of Costa Rica. This area represents a Hispanic population which has one of the
highest prevalences of asthma in the world (24% in children), making it uniquely suited for the exploration of the
metabolomic underpinnings of asthmatic lung function. GACRS is a family-based study, which provides a unique
opportunity to examine the causal relationship between SNPs, metabolites, and lung function in a framework
that is robust to population stratification and phenotypic misspecification and can accommodate unbiased
screening steps. The objective of this proposal is to identify pleiotropic associations of metabolites and lung
function (i.e., SNPs associated with both lung function and at least one metabolite) (Aim 1), identify metabolomic
determinants of lung function (Aim 2), and examine the genetic effect on lung function as mediated by the
metabolites (Aim 3) among Hispanic children with asthma in GACRS and the Childhood Asthma Management
Program (CAMP) with replication in Hispanic, Black, and Non-Hispanic White children in VDAART and
replication/ generalizability to adults (Hispanic, Black and Non-Hispanic White) in the NHLBI Trans-Omics for
Precision Medicine (TOPMed) program.

Public health relevance
Project Narrative Asthma has both genetic and environmental risk factors and therefore, metabolites play a key role. However, the path from gene to metabolite to disease remains unclear and requires further study. Given the high rate of asthma among Hispanic children in Costa Rica, the objective of this proposal is to leverage the family-based design to examine how single nucleotide polymorphisms (SNPs) and metabolites act on lung function among Hispanic children with asthma.